Data Sharing and Archiving for Demographic Research - Supplement #2 (NICHD)

Project Summary/Abstract
Data Sharing for Demographic Research (DSDR) is a Population Health Data Archive that makes
research data with external validity available for secondary analysis. These data enable researchers to make
valid inferences about the health of Americans. Access to high-quality, generalizable data about populations
facilitates scientific advancements at a pace that is not possible when researchers are limited to the data
resources they can produce by themselves. Analysis of the research data in the Archive can lead to improved
treatments and health outcomes. Specifically, FAIR (Findable, Accessible, Interoperable and Reusable)
research data are critical to transparency and research reproducibility as well as making it feasible for
scientists to combine data of different types and from different sources for a more nuanced understanding of
the context of health outcomes and behaviors.
By depositing with DSDR, data collectors comply with NIH regulations to share data. To make data as
accessible as possible to the research community, DSDR makes all data (public, controlled, and restricted)
available at no charge while protecting human subjects. DSDR adheres to the FAIR data principles and is
hosted by ICPSR of the Institute for Social Research (ISR) at the University of Michigan. DSDR leverages the
capabilities and capacities of ICPSR, ISR, and the University to support research on maternal and child health,
the lifecourse, health disparities, migration, relationship formation and dissolution, and more in the U.S. and
globally.
To meet the priorities set forth by NICHD, DSDR proposes five main aims: 1) Sustain and build the
collection of data, documentation, and other support files, 2) Improve discoverability and exploration of data, 3)
Augment access to restricted data, 4) Enable the combining of new types of data (e.g., biomarkers,
neuroimages, and administrative records) with survey data, and 5) Offer training and perform outreach to
engage the demographic research community. ICPSR's high-quality curation, creation of standardized
information describing the data, dissemination of complete documentation, and training opportunities ensures
researchers can more easily find, evaluate, and analyze data collected by others to answer new and innovative
research questions while upholding respondent privacy expectations.

Public health relevance
Project Narrative Data Sharing for Demographic Research (DSDR) is a Population Health Data Archive that makes research data with external validity available for secondary analysis. These data enable researchers to make valid inferences about the health of Americans. The overall mission of DSDR is to make research data as accessible as possible while still protecting human subjects.